Applying a Human-Centered Design Approach to Enhance Bioengineering Education

Project Summary
Capstone Senior Design courses enable bioengineering (BIOE) seniors to engage with the design
process and apply technical fundamentals and industry related topics, ultimately generating a functional
prototype. Our capstone program at Rice University, solicits project ideas from research faculty, physicians,
and industry leaders. Interdisciplinary teams drive the prototype development throughout the year and
submit oral presentation and documentation deliverables. Students in our capstone program enjoy immense
advantage offered by a well-equipped design facility and infrastructure at Rice University to support projects
from the Texas Medical Center, home to the world’s largest children’s and cancer hospital and the largest
medical city in the world. These strengths, along with the cross-disciplinary teams (mechanical engineering,
electrical engineering and global health technologies) rigorous senior design documentation, and oral
deliverables, lead to teams placing nationally in competitions each year.
Effective capstone program design, however, demands an engaged clinical experience, an area lacking
in many existing programs, including ours. To address this, we propose the creation of a novel clinical
immersion program with a focus on human centered design and inequities in healthcare delivery. Our
program will consist of a cohort of five bioengineering seniors selected through an application process and 3
pediatric residents from Baylor College of Medicine. The cohort will attend didactic lectures on topics such as
design process, needs finding, inequities in healthcare delivery, universal design, storyboarding, stakeholder
communication and design de-risking. Students will apply their learnings by immersive engagement in two
clinical environments: 1) Pediatric Intensive Care Unit in Texas Children’s Hospital and 2) Texas Heart Institute.
Exercises such as iterative storyboarding, daily individual and group reflections and case study research on the
evolution of a device design will elucidate areas of clinical challenges and critical context that can be discussed
daily with faculty mentors. These exercises will also serve as student artifacts to be shared with all members of
the senior design course followed by formative quiz assessments. Two unique features of our clinical
immersion program include a) use of a coproduction model of education that involves equal involvement of
students in program design resulting in increased ownership and engagement among the cohort1 and b)
involvement of pediatric residents in observations and discussions with the bioengineering students offering
an active discussion about different aspects of the clinical challenge. Through our clinical immersion program,
the cohort will have the ability to engage in conversations with a diverse set of stakeholders not limited to
medical practitioners. Ultimately, students will identify a set of unmet clinical needs reflecting inequities in
healthcare delivery and perspectives not addressed previously. This program highlighting the inequities in
healthcare deliveries will train BIOE students to develop human centered biomedical solutions.

Public health relevance
Project Narrative Many bioengineering programs offer the strength of an interdisciplinary team approach in their Capstone Senior Design courses. The lack of real-world clinical context limits the scope and breadth of coursework, however, leaving a critical gap in bioengineering training and ultimately design. We propose the use of a human-centered design approach via a clinical immersion program to prioritize inequities in healthcare delivery in our capstone program, better addressing problems of all populations and better equipping our students for the workforce.